KBASE2: Korean Brain Aging Study, Longitudinal Endophenotypes and Systems Biology

Project Summary/Abstract
The Korean Brain Aging Study for the Early Diagnosis and Prediction of AD (KBASE) is a comprehensive
prospective cohort study launched at Seoul National University (SNU) in 2014 using a similar design and
methods as the North American Alzheimer’s Disease Neuroimaging Initiative (ADNI). The KBASE cohort
consists of well-characterized participants including cognitively normal (CN) controls with a wide age range (20
to 90 years), mild cognitive impairment (MCI) and AD dementia (AD). A unique aspect of KBASE is the
systematic longitudinal collection of comprehensive clinical, cognitive and lifestyle data, multimodal
neuroimaging (MRI/MRA, DTI, rsfMRI, amyloid, tau and FDG PET), and bio-specimens in Korea for the first five
years (“KBASE1”). Some KBASE data have been analyzed and reported but much of the extensive KBASE data
set and samples await comprehensive analysis. The proposed project (“KBASE2”) represents a collaboration
between the NIA Alzheimer’s Disease Sequencing Project (ADSP) and partners, Indiana University (ADNI
Genetics Core, Indiana NIA-designated ADRC, and IU Network Science Institute), the KBASE team at SNU in
Korea, University of Southern California (USC), and the University of Pennsylvania. Over 1000 whole genome
sequences (WGS) of Korean participants will be contributed to the ADSP, and the extensive ADSP multi-ethnic
data set will be analyzed. WGS data will be harmonized by the NIA Genetics and Genomics Center for AD
(GCAD) and shared via the NIA Genetics of AD Data Storage Site (NIAGADS). The Laboratory of Neuroimaging
(LONI) at USC will support sharing of MRI and PET and related endophenotypes, as it does for ADNI. KBASE2
will continue longitudinal data and sample collection and provide high throughput WGS and RNA-Seq as well as
data harmonization and sharing (Aim 1), perform intensive brain network-based analyses of longitudinal amyloid,
tau, neurodegeneration and vascular (A/T/N/V) imaging biomarkers in relation to clinical data (Aim 2), employ
integrative systems biology and functional genomics methods to analyze multi-omics data for association with
A/T/N/V biomarkers for AD, and provide new insight into AD biomarker-related dysregulated gene modules and
pathways (Aim 3). The overarching concepts driving this multidisciplinary international collaborative project are
that 1) development of precision medicine for AD and related disorders (ADRD) requires systematic multi-modal
biomarker collection in diverse cohorts during early at-risk stages of disease to identify robust diagnostic,
prognostic and therapeutic targets and 2) sophisticated analytic strategies that address the complexity of multi-
layer multimodal data and heterogeneous and diverse participant cohorts are essential. We hypothesize that
integrative longitudinal analysis of genetic and -omics networks with structural and functional brain networks will
yield new diagnostic and treatment-relevant insights related to A/T/N/V and other aging related pathways.
Results of this collaboration and data sharing will facilitate translation of ADSP findings for therapeutic
development in support of the National Alzheimer's Project Act goal of prevention and treatment of AD by 2025.

Public health relevance
Project Narrative Alzheimer’s disease (AD) and related dementias are a widely recognized major public health problem in the U.S. and globally. The proposed international collaborative project will contribute rich longitudinal biomarker and clinical data and over 1000 whole genome sequences on a Korean cohort to the NIA AD Sequencing Project and related research programs. Well-characterized multi-ethnic genomic data sets are a major priority for AD research. KBASE2 brings a multidisciplinary team together to complete state of the science integrative analyses of the clinical, genetic, brain network and multi-omics data to accelerate the identification of new potential therapeutic targets.